The Role of Gab2 Signaling in Thromboinflammation

Inflammation is a protective response of the organism to fight against invading pathogens or endogenous danger
signals such as damaged cells. However, when the response goes unchecked, it results in tissue damage and
contributes to the pathogenesis of various diseases such as rheumatoid arthritis, neurodegenerative diseases,
heart diseases, and stroke. Recent studies strongly indicate that Inflammatory processes play a crucial role in
the pathogenesis of venous thromboembolism (VTE). Although the signaling pathways activated by the
inflammatory mediators have been extensively studied, still key gaps exist in our understanding of how cells
exposed to various inflammatory stimuli integrate signals from diverse receptors to activate common downstream
signaling pathways to stimulate transcription factors such as NF-kB and AP-1 and induce the expression of
proinflammatory cell adhesion molecules, cytokines, procoagulant clotting factors. Activation of Toll-like
receptors (TLRs), tumor necrosis factor (TNF), and interleukin 1 (IL-1) receptors by their ligands triggers the
formation of multi-subunit signaling complexes that include many scaffolding proteins. Gab2 (growth factor
receptor-bound protein 2 (Grb2)-associated binding protein 2) is a scaffolding adapter protein that integrates and
amplifies signals from a wide variety of extracellular stimuli, including growth factors, antigen receptors, and cell
adhesion molecules. Gab2 is shown to play a critical role in allergy, cancer, and hematopoiesis. However, to
date, the role of Gab2 in inflammatory signaling is unknown. Our preliminary studies show that Gab2 silencing
attenuates TNFα-, IL-1β-, and LPS- induced expression of cell adhesion molecules, cytokines, and procoagulant
cofactor, tissue factor in endothelial cells. Gab2 silencing has been found to attenuate the activation of the NF-
κB and MAPKs. We hypothesize that Gab2 plays a central role in TNFR1-, IL-1R1-, and TLR4- mediated
inflammatory signaling pathways in endothelial cells, and Gab2-dependent signaling contributes to the
pathogenesis of VTE. In Aim 1, we will elucidate the mechanism by which Gab2 transmits TNFR1-, IL-1R1-,
and TLR4-mediated signaling in endothelial cells, including the structural requirements of Gab2 in mediating
TNFR1-, IL-1R1, and TLR4-mediated signal transduction and its activation of TAK1 (TGF-β-activated kinase 1),
a key modulator of transcription factors NF-κB and AP-1. In Aim 2, we will determine the role of Gab2
inflammatory signaling in sepsis and the pathogenesis of VTE using Gab2-deficient mice and wild-type littermate
controls. Impact: Establishing Gab2 as a crucial player in inflammatory signaling and elucidating the mechanism
underlying how Gab2 integrates and transmits signals induced by different inflammatory signaling pathways
would lead to new and exciting research on Gab2’s role in innate immunity and inflammation. Data from our
studies will provide novel insights for designing new and effective therapies to treat inflammatory disorders.

Public health relevance
PROJECT NARRATIVE Immune cells and inflammatory processes contribute to venous thromboembolism. The current proposal investigates the role of Gab 2, a scaffolding signaling protein, in inflammatory signaling induced by multiple receptors. The proposed research investigates how Gab2 integrates signals induced by various inflammatory mediators to a common pathway downstream and obtains evidence to a proof-of-concept that Gab2-mediated thromboinflammatory signaling contributes to the pathogenesis of venous thromboembolism. The knowledge gathered from the proposed studies will add new insights into inflammatory signaling pathways and provide clues on potential therapeutic strategies to treat inflammatory disorders.